Georgia NCI Community Oncology Research Program (GA NCORP)

Project Summary
This renewal application is for the statewide Georgia National Cancer Institute (NCI) Community Oncology
Research Program (GA NCORP) Community Site, which represents a collaboration between the two largest
community oncology clinical trial programs in Georgia, Northside Hospital Cancer Institute in Atlanta and the
Nancy N. and J.C. Lewis Cancer & Research Pavilion at St. Joseph's/Candler in Savannah, and the Georgia
Center for Oncology Research and Education (Georgia CORE) in Atlanta. Georgia CORE provides network
affiliation for five contracted healthcare organizations across Georgia. In 2016, GA NCORP Affiliates together
provided care to approximately 17,000 newly diagnosed patients with cancer and enrolled 1,198 patients to
NCI-sponsored trials since August 2014. Through an integrated organizational and leadership structure,
leading cancer researchers of GA NCORP are poised to build on a 29-year history of collaboration to further
enhance the quality of cancer care in Georgia through improved access to NCI-sponsored trials and through
the implementation of the goals of GA NCORP. The overall goal of GA NCORP is to bring cancer clinical
research studies to individuals in their own communities through a statewide network utilizing shared
infrastructure. This approach generates a broadly applicable evidence base that contributes to improved
patient outcomes and a reduction in cancer disparities. Four specific aims are proposed to achieve the overall
goal of GA NCORP: 1) to increase the number of eligible patients at risk for, or diagnosed with, cancer and
who are provided access to, and enroll in, cancer clinical trials within their community; 2) to enroll participants
from underrepresented populations across all study types and settings to reduce cancer disparities
(populations include racial/ethnic minorities, sexual and gender minorities, adolescents, young adults, elderly,
and rural residents); 3) to create a balanced trial portfolio between treatment trials and cancer control and
prevention trials; and 4) to increase accrual and expand network-wide participation in cancer care delivery
research. Achieving these aims will improve the quality of care in Georgia through increasing cancer research
in local communities, identifying best practices for research accruals, and maximizing capacity and expertise
for cancer research statewide.

Public health relevance
Project Narrative GA NCORP Community Site addresses two important challenges in US public health: expanding cancer research to a broader population and including underserved populations in cancer research. Advances in clinical care and scientific discovery are not currently equally available to all races and ethnic groups. GA NCORP will continue to analyze data to identify areas for potential improvement, identify proven best practices, and utilize the expertise of research network affiliates and disparities experts to develop and enhance efforts to achieve equitable access to clinical trials.